Scaled identification of receptor-targeted AAVs for potent and cell type-specific transgene delivery

PROJECT SUMMARY:
This interdisciplinary established team initiative will provide the neuroscience community with a
toolkit of engineered adeno-associated virus (AAV) reagents for cell type-specific transgene
expression in non-transgenic rodents and non-human primates (NHP).
While existing AAV capsids engineered for enhanced BBB crossing in macaque NHP from
us and others vastly outperform AAV9 after intravenous injection, they remain far short of the
potency of equivalent tools in rodent. To achieve functional parity, we will leverage our established
track-record in AAV capsid engineering paired with mechanistic insight based on blood-brain
barrier (BBB) receptor-mediated transcytosis pathways we recently discovered. The resulting
NHP capsids will enable brain-wide payload delivery, e.g. for efficient primate cell type-specific
enhancer screening, and utilization of existing gene regulatory element strategies for neuronal
cell type specificity (Aim 1). Our approach will utilize structure-informed capsid libraries selected
in vitro against BBB receptors known to promote strong transcytosis and we will scale up our
screening technologies for discovery of additional novel BBB receptors engaged by AAVs
identified through mechanism-agnostic directed evolution.
We will generate a toolkit of >60 AAV capsids each for direct and systemic delivery, in
addition to >30 AAV cargo miRNA target site designs with distinct neuronal cell subtype-specific
expression patterns in mouse (Aim 2). Using ‘null’ AAV capsids that require an additional non-
natural membrane protein interaction in order to infect cells, we will mine recently announced
comprehensive mouse brain cell transcriptomic atlases and employ a custom automation platform
for high throughput in vitro AAV engineering against membrane proteins with cell subtype-specific
patterns of expression. In parallel, we will use spatial transcriptomics and machine learning to
identify and characterize novel post-transcriptional gene regulatory elements. These capsids and
miRNA target sites will synergize with and complement enhancer-AAV strategies for neuronal cell
type specificity.
To ease adoption of these tools, we will establish a rigorous reagent characterization and
dissemination pipeline (Aim 3). Identified reagents will be validated in vivo via quantification of
cell type potency and specificity with all metadata and data made available through online
repositories. Reagents will be adapted for broad dissemination in plasmid and vector formats via
an established collaborative network.

Public health relevance
PROJECT NARRATIVE This project will establish a pipeline for scaled identification of genetic access reagents for neuronal cell type-specific payload expression by complementing enhancer-AAV strategies with a broad toolkit of AAV capsids for potent and cell type-specific vector internalization and AAV cargo post-transcriptional regulatory elements for cell type-specific transgene expression in mouse. Coupling receptor-targeted in vitro engineering of AAV capsids with high throughput screens to identify optimal non-human primate blood-brain barrier transcytosis receptors, we aim to iteratively engineer noninvasive, potent, broadly neuronal targeting AAVs for macaque non- human primates, enabling cell type specific payload expression through modular combination with gene regulatory elements. To enable broad dissemination throughout the neuroscience community, these tools will be extensively validated, catalogued, and shared to catalyze the investigation of brain function and, ultimately, contribute toward cures for brain diseases.